Brief Research In Aging and Interdisciplinary Neurosciences (BRAIN)

Project summary
The Department of Neurology at Columbia University Medical Center serves as a rich site for multidisciplinary
neurological research, with particular focus on disorders associated with the aging nervous system. This
proposal seeks to continue funding for positions for 25 preclinical students participating in the Brief Research in
Aging and Interdisciplinary Neurosciences (BRAIN) program each summer. For the BRAIN program, we have
developed a comprehensive approach to develop a formal research program for predoctoral students early in
developing careers in biomedical, behavioral and clinical research. The work is collaboratively approached
through brief but intensive mentored summer research training experiences for these students. The research
training provides opportunities in basic, behavioral and clinical research through ongoing research in the fields
of basic neuroscience, neuropathology, neurogenetics, neuropsychology, stroke, Alzheimer disease and
related disorders, motor neuron disease, Parkinson disease and related disorders, and epilepsy, as well as
neurologic clinical trials treating patients with these disorders. In addition, a comprehensive structured research
education curriculum is delivered over the course of the intense research experience, with topics including
responsible conduct of research and methods to enhance reproducibility, basic research methodologies,
introductions to abstract authorship and poster presentations, and introduction of statistical concepts and
approach to analyses, as well as epidemiologic and pathophysiologic reviews of the most common neurologic
disorders associated with aging and thus likely to be studied. Our institution has the strongest track record of
developing academic neurologists of anywhere worldwide, and this short-term, intense program builds upon
this wealth of resources through hands-on introductions to neurological research, comprehensive review of
principles of research, and thus assures the best opportunity for these students to develop research careers in
the field and be prepared to developing research projects of their own.

Public health relevance
Project Narrative The Brief Research in Interdisciplinary Neurosciences (BRAIN) program offers a rich summer research opportunity at the Vagelos College of Physicians and Surgeons at Columbia University for predoctoral candidates interested in research in the field of aging, particularly among neurologic disorders including neurodegenerative illnesses such as Alzheimer, Parkinson and Lou Gehrig diseases, as well as a broad array of related neuroscience disciplines. This program provides an ideal environment for students to pursue careers in research studying diseases often without cure or even effective treatments, and thus pose a significant public health burden. In addition to researching neurological diseases, students learn essential principles of research at a critical training period, providing skills to launch successful research careers.